Controlling Bacterial Amyloid Formation and the Influence of Curli Subunits on Pathogenic Alpha-synuclein Aggregation

Escherichia coli (E.coli) and other enteric bacteria are a major cause of human diseases. Biofilm formation
contributes greatly to bacterial persistence and antimicrobial resistance in the host. A striking aspect of biofilms
is the “division of labor” that drives unique subpopulation development. Many Enterobacteriaceae, such as E.
coli, produce functional amyloid fibers called curli as a major proteinaceous component of their biofilm
extracellular matrix. It is now clear that functional amyloids are widespread, with examples found throughout
cellular life. The curli system in E. coli provides a rich and high throughput genetic and biochemical toolbox for
the study of amyloid formation. The work has contributed to a curli assembly model where the main fiber
component CsgA and the minor subunit CsgB are secreted through the outer membrane-located CsgG. CsgB
is anchored to the extracellular surface of the bacterium via the action of CsgF, whose ability to phase
separate is tightly linked to its function in curli biogenesis. Soluble CsgA is targeted to the CsgG secretion
channel by CsgE, then secreted. CsgA subunits that inappropriately polymerize in the periplasm are inhibited
from amyloid accumulation via CsgE and CsgC. The exquisitely-controlled curli biogenesis system ensures
that E. coli is not exposed to the potentially cytotoxic outcomes of amyloid formation. Work here will also
explore how E. coli cells differentiate into transcriptionally distinct populations during biofilm development.
Uncontrolled or inappropriate amyloid formation are the genesis of several neurodegenerative diseases,
including Parkinson’s. Colonization of mice with curli amyloid producing bacteria results in alpha-synuclein
amyloid formation and Parkinson’s-like symptoms. Furthermore, purified CsgA protein can accelerate alpha-
synuclein amyloid formation in vitro. Therefore, it is imperative to learn how E. coli controls curli amyloid
formation and how CsgA can accelerate alpha-synuclein amyloid formation. Interestingly, CsgC from E. coli
can inhibit CsgA and alpha-synuclein amyloid formation. Knowledge gained from the following experiments will
have implications for microbial pathogenesis, general protein folding, and amyloid biogenesis, thus paving the
way for new therapies that rationally target these critical biological processes. To better understand curli
biogenesis and develop therapeutics that target curli amyloid formation or function, the dynamic mechanism
curli amyloid secretion/assembly will be determined using single molecule super-resolution microscopy and
other biophysical techniques, that will reveal the location, order, and timing of the assembly of the large curli
protein export machinery (Aim 1). Population development in amyloid-dependent biofilms will be studied. In
Aim 2 CsgC protein chaperone and 2-pyridone molecules will be studied for their CsgA and alpha-synuclein
polymerization inhibitory activities. Together the successful completion of these aims will give an overall
understanding of the mechanism of amyloid inhibitory activity and the interactions between bacterial amyloid
formation, biofilm development and neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE: Many Gram-negative bacteria encode the genes necessary for the formation of functional amyloid fibers called curli that contribute to biofilm formation. Curli amyloids produced by gut bacteria can accelerate Parkinson’s-like symptoms in mice. Here, we focus on understanding curli biogenesis and how curli can interact with human proteins to initiate pathogenic pathways that ultimately lead to neurodegeneration.